MOONSHOT - TOPIC 423 - AN INTEGRATED MULTI-LEVEL DECISION SUPPORT PLATFORM TO ADDRESS PATIENT-CENTERED AND EVIDENCE-BASED SOCIAL DETERMINANTS OF HEALT

A strong body of evidence demonstrates that addressing Social Determinants of Health (SDH) within healthcare
systems advances cancer treatment adherence and outcomes. Preventable cancer deaths continue to occur
because of un-addressed SDH challenges across socioeconomic groups and races. Integrating SDH along with
clinical information within operational CDS systems built into Electronic Health
Records (EHRs) is an essential approach for addressing cancer disparities. We propose developing a software
aimed at: (1) Closing the gaps in electronic SDH screening, CDS, and clinical workflows (2) Developing a patientcentered
and evidence-based SDH screening and CDS tool (3) Integrating the proposed tool within existing
oncology workflows (4) Establishing a framework for continuous assessment and improvement of the proposed
solution.
Our three-pronged approach combines expertise from software engineering, oncology, and social epidemiology.
Our solution will enhance the existing oncology practice by collecting timely and relevant SDH information from
patients, together with evidence-based clinical actions addressing psychosocial needs of the patients, resulting
in improved cancer treatment outcomes. It will streamline communication and decision support for the patient’s
care team and community-based organizations dedicated to addressing patient’s needs, potentially leading to
reduce disparities and the burden of a cancer diagnosis on the patient and society.